Protein Kinase Novel 2 (PKN2) in heart

PROJECT SUMMARY
The Protein Kinase Novel (PKNs) family of kinases, also known as Protein Kinase C-related kinases, belong to
the PKC superfamily. A single nucleotide polymorphism at the Pkn2 locus is associated with greater risk for
coronary artery disease/myocardial infarction, and elevated levels of PKN2 protein are associated with heart
disease, highlighting the importance of PKN2 in heart. Global deletion of Pkn2 in mouse results in lethality at
embryonic day (E) 10 with cardiac defects. Conditional deletion of Pkn2, utilizing SM22α-Cre mice, results in
partial lethality between E13.5 and weaning, with surviving mutants displaying abnormal cardiac phenotypes.
These observations strongly suggest that PKN2 plays a critical role in the developing heart, however, because
SM22α-Cre is expressed not only in early developing cardiomyocytes, but also in smooth muscle, skeletal
muscle, and myeloid and lymphoid immune cells, this previous study does not address the cardiomyocyte-
specific requirement. Intriguingly, a recent study showed that deletion of Pkn1 and Pkn2 in adult
cardiomyocytes, utilizing αMHC-MerCreMer mice, did not affect basal cardiac function, but protected mice from
pressure overload- and angiotensin II-induced cardiac hypertrophy and heart failure, suggesting that PKN
inactivation could be a unique therapeutic target for heart failure. The contradiction between the partial
embryonic lethality of SM22α-Cre:Pkn2 knockout mice and protective effects observed in adult αMHC-
MerCreMer:Pkn1/2 double knockout mice highlights a critical need to define potential roles of PKN2 in
cardiomyocytes at different developmental stages. To address this contradiction, we have generated novel
Pkn2 cardiomyocyte-specific constitutive knockout (cKO) and Pkn2 tamoxifen-inducible cardiomyocyte-specific
knockout (icKO) mouse models utilizing Xmlc2-Cre and Tnnt2-MerCreMer mouse lines, respectively. Upon
preliminary characterization, Pkn2 cKO mice displayed partial postnatal lethality and cardiac morphological
defects as early as E12.5. Echocardiographic studies of surviving mutants revealed a dilated cardiomyopathy
phenotype in Pkn2 cKO mutants at both 1 and 3 months of age. In contrast to published reports that loss of
Pkn2 in adult cardiomyocytes does not affect basal cardiac function, our preliminary observations suggest that
Pkn2 deficiency in developing cardiomyocytes is detrimental. Taken together, the above evidence leads us to
the hypothesis that PKN2 plays distinct roles at different stages of cardiomyocyte development through the
phosphoregulation of specific substrates. Accordingly, our specific aims are: 1. To elucidate the role of PKN2 in
cardiomyocytes by analysis of cardiac and cardiomyocyte structure and function in Pkn2 cKO mice, and to
identify endogenous substrates of PKN2 in cardiomyocytes by utilizing unbiased phosphoproteomics and a
chemical-genetics approach with an analog-sensitive PKN2 mutant, and 2. To determine the cardiomyocyte-
specific requirement for PKN2 in postnatal development by analysis of Pkn2 icKO mice.

Public health relevance
PROJECT NARRATIVE Protein kinases orchestrate a wide range of cellular processes and play integral roles in cardiac development, function, and disease, making them attractive therapeutic targets. A member of the Protein Kinase Novel (PKN) family, PKN2, is dysregulated in numerous human cardiac conditions and is essential for cardiac development. Proposed studies will help us to understand the biological function of PKN2 in cardiomyocytes at molecular, cellular, and physiological levels, and identify critical PKN2 substrates as well as determine a safe therapeutic window for the potential application of PKN2 inhibitors in heart failure.